The impact of targeting CD40-CD154 pathway in nonhuman primate vascularized composite allograft model

Abstract
Vascular composite allotransplantation (VCA) is the most immediately available therapy for individuals who
have suffered irreparable tissue damages or deformities. While the technical aspects of VCA have rapidly
advanced for these patients, the outcomes of VCA still lag behind those of other solid organ transplantation.
The dramatic difference in outcomes highlights the inadequacy of current immunosuppressive regimens in
VCA, which are largely borrowed from other organ transplantation, particularly kidney transplantation, where
patients are immunologically more naïve. The higher immunogenicity (or susceptibility to rejection) of VCA may
be attributed to (1) the inclusion of multiple tissues (i.e. muscle, skin, nerve etc.) in the transplant, (2) the
exclusive use of deceased donors for VCA, and (3) pre-transplant management of trauma including transfusion
prior to VCA. These factors will contribute to VCA rejection by expanding allo-specific immune cell repertoire,
priming innate cells (trained immunity), and sensitizing recipients, respectively.We have shown that targeting
the CD40/CD154 signaling pathway with anti-CD154mAb successfully promote long-term graft survival of
kidney allograft in naïve recipients. Furthermore, anti-CD154mAb showed superior efficacy in sensitized
recipients compared to tacrolimus-based conventional immunosuppression. Together with cytolytic induction,
anti-CD154mAb effectively prevented post-transplant humoral response, eliminated antibody-mediated
rejection (AMR) and significantly prolonged graft survival in sensitized recipients, all without introducing
additional viral complications or malignancy. Given its exceptional efficacy in organ transplantation, particularly
in sensitized recipients, we hypothesize that targeting the CD40/CD154 singling pathway can efficiently
regulate the host immune response following VCA, even in cases where recipient have been sensitized by
primary trauma care. This approach may create a therapeutic window to induce donor-specific tolerance. We
will evaluate anti-CD154mAb approach in combination with either apoptotic donor cells or complement
inhibition to re-establish an immune repertoire that favors transplantation tolerance. To explore this hypothesis,
we propose 3 specific aims: 1) To test the efficacy of anti-CD154mAb in a naïve and sensitized nonhuman
primate VCA models. 2) To determine efficacy of antigen-specific and non-specific pro-tolerance approaches in
NHP VCA recipients. 3) To identify the functional phenotype of allo-specific T and B cells repertoires required
to establish tolerance in VCA recipients.

Public health relevance
PROJECT NARRATIVE Vascularized composite allografts (VCAs), which involve the transplantation of a combination of skin, muscle, bone, nerves, offer immediate therapy for individuals who have suffered irreparable tissue damages or deformities (i.e. face, hand etc.). However, VCAs are highly susceptible rejection and also requires life-long immunosuppression which is often toxic to the patients. Therefore, this study aims to utilize a preclinical nonhuman primate model to explore novel therapeutic strategies targeting CD40/CD154 signing pathway with anti-CD154mAb. The ultimate objectives are to minimize VCA rejection, preserve protective immunity, promote tolerance, and optimize patient health.